DOSE RESPONSE OF LIPOPROTEIN LIPASE TO ISOPROTERENOL IN NORMAL WEIGHT AND OBESITY

The purpose of this study is to establish a dose-response curve to determine the minimum dose of isuprel required to produce a maximum decrease in gluteal atlpl activity and in ATLPL mRNA, and to establish the time course of the enzyme response.